Mechanism of inflammation in deficiency of adenosine deaminase 2

Project Summary
DADA2 is an inborn error of immunity characterized by systemic inflammation with vascular involvement
and bone marrow failure. Biallelic mutations in ADA2 are responsible for this recessive condition, though
symptomatic carriers with a single deleterious variant are increasingly recognized. How pathogenic ADA2
variants translate to the heterogeneous disease manifestations remains unclear. Underscoring the
importance to better understand DADA2, our work demonstrated the potential for ~35,000 patients
worldwide.
We found that missense ADA2 variants with residual enzymatic activity are associated with the
inflammatory phenotype while loss of function (LOF) variants are linked to bone marrow failure in DADA2.
We now provide evidence that missense ADA2 variants cause protein misfolding and retention in the
endoplasmic reticulum, leading to activation of the unfolded protein response (UPR). We hypothesize that
activation of UPR in monocytes by misfolded ADA2 protein induces tumor necrosis factor production to
drive inflammation in DADA2, while the absence of ADA2 protein impairs hematopoiesis. This mechanism
also potentially explains features of DADA2 in some heterozygous carriers of missense ADA2 variants.
We will pursue this hypothesis through 2 complementary but independent aims. Aim I will examine the
activation of three main UPR pathways and cytokine production in monocyte-derived macrophages from
healthy controls, patients with DADA2, and heterozygous carriers of pathogenic ADA2 variants. We will
validate the results in gene-edited cell lines with disease-associated variants. We will evaluate UPR
activation in inflamed tissues from patients, and compare the transcriptomic landscape, including signatures
of TNF and UPR activation, between disease phenotypes. We will explore how carriage of misfolded ADA2
may impair the trafficking and function of wildtype ADA2, leading to inflammation. Aim II will evaluate the
therapeutic effects of TNF inhibitors, UPR inhibitors, gene therapy and enzyme replacement therapy on
cytokine production and immune activation by monocyte-derived macrophages from patients with DADA2.
Extending our analysis to the BMF phenotype, we will study the impact of these therapies on in vitro
differentiation of ADA2-deficient hematopoietic stem and progenitor cells. In an exploratory sub-aim, we will
seek to establish an in vivo model of DADA2 by engrafting gene-edited hematopoietic stem cells into
humanized mice. The proposed studies will inform the development of personalized medicine for DADA2
and more broadly illuminate how defects in one gene can lead to variable disease phenotypes.

Public health relevance
Project Narrative Deficiency of adenosine deaminase 2 (DADA2) is an inborn error of immunity characterized by systemic inflammation, vasculitis and bone marrow failure. This proposal investigates how different genetic variants in the ADA2 gene result in the variable disease phenotypes. The proposed studies will inform the development of personalized medicine for patients with DADA2 and more broadly illuminate how defects in one gene can lead to different disease manifestations.